Molecular Basis of Human Visual System Disorders

Abstract
The goal of this project is to better understand underlying disease mechanisms of Retinitis Pigmentosa (RP),
one of the most common forms of inherited retinal degeneration that affects an estimated 100,000 people in
the United States alone. To accomplish this, functional studies will be performed for REEP6, a novel RP
disease gene that is recently identified. In parallel, additional genes associated with RP will be identified by
further characterizing a large cohort of 1,500 RP patients we have recruited during last funding cycle. Through
establishing and follow up functional studies of mice model for these newly RP associated disease gene, we
expect to gain new insights of disease mechanisms as well as lay the foundation for developing new diagnosis
and treatment methods.
Mutations in known RP genes account for about 60% of all cases in the European population, suggesting that
many additional RP genes remain to be identified. To identify additional RP disease genes, we have collected
more than 1,500 patient families from around the world. Screen for mutations in known arRP disease genes
suggests that about 600 of these families are likely to carry mutations in novel RP disease genes. Therefore,
this collection represents a well characterized, rich resource for identifying new genes that can cause RP.
Indeed, whole exome sequencing of a subset of these 600 proband have led the discovery of ten novel
disease genes, including the recently identified REEP6 gene. In this proposal, we plan to identify the
underlying mutations the remaining proband and newly recruited patients using a combination of whole exome
sequencing, bioinformatics, statistics, and functional studies. In parallel, we will conduct functional studies of
the newly establish Reep6 knock out and knock in mice to reveal novel interesting underlying disease
mechanisms. Our Specific Aims are to:
Specific Aim 1. Characterize the mechanism of action of the novel RP disease gene REEP6
Specific Aim 2. Identify and characterize novel RP candidate disease genes
Specific Aim 3. Investigate noncoding mutations in RP patients
Discovery and characterization of novel RP genes will assist the development of new diagnostic tools and
treatments. In addition, since mutations in RP disease genes also cause other retinal dystrophies, functional
studies of additional RP disease genes will provide important insights into the molecular mechanisms
underlying both RP and retinal dystrophies in general.

Public health relevance
Description The goal of this research project is to identify and perform functional studies of novel genes that are involved in Retinitis Pigmentosa (RP). As one of the most common forms of inherited retinal degeneration that affects an estimated 100,000 people in the United States alone. Due to the genetic and clinical heterogeneity of the disease, identifying and understanding the molecular basis of the disease is the essential first step for accurate diagnosis as well as developing new treatment methods for the disease.